INFECTIVITY OF NORWALK &NORWALK LIKE VIRUSES

The purpose of this research study is to determine the amount of Snow Mountain virus that causes sickness. When this is determined the researchers will be able to test water and to recommend better ways of removing Snow Mountain virus to reach safe levels.